Biological systems underlying the impact of potential threat on cognitive control in mood disorders

7. Project Summary/Abstract
Depression exacts a great personal cost in pain and suffering and an economic cost of approximately $102
billion a year due to lost work productivity. A key factor underlying depressive mood and functional
impairment in depression is disrupted cognitive functioning. Disrupted cognitive functioning is an enduring
feature of depression that is not readily treated. Preliminary work indicates that the degree of acute stress-
induced anxiety experienced during a cognitive task has the potential to explain heterogeneity in prefrontal
cortex (PFC) mediated cognitive control deficits in depression. Animal work points to the central role of the
central nucleus of the amygdala and the locus coeruleus-norepinephrine (LC-NE) system as mediating stress-
induced anxiety. However, the specific biological mechanisms underlying stress-induced anxiety and their
contributions to PFC impairment, depressive mood, and decreased functional outcomes in mood disorders
remain unclear. Clarifying the biological mechanisms underlying stress-induced anxiety and its effects on
cognitive control may pave the way for identifying specific individuals for whom interventions that selectively
target cognitive control deficits in depression will be most effective. Aim 1 of this study proposes to evaluate the
contributions of the LC-NE system to variability in stress-induced anxiety; and Aim 2 will examine associations
among LC, ventral tegmental area(VTA)-mesocortical dopaminergic circuit, and cognitive control. To achieve
these aims 140 men and women aged 30-50 years presenting with depression spectrum disorders (i.e., major
depressive disorder, persistent depressive disorder, or other specified depressive disorder) and 40 healthy
controls will complete cognitive tasks—taxing the representation, maintenance, and updating aspects of
cognitive control—under potentially threatening and non-threatening conditions. Activation of neural circuits
will be assessed with functional magnetic resonance imaging (fMRI) optimized to localize and assess activity
within the LC, VTA, and cognitive control networks (i.e., within the dorsolateral prefrontal cortex). In addition,
concurrent pupillometry will be collected and used as a secondary index of LC activation, given its high
correlation with LC neural firing. We will assess the magnitude of the stress-response using endocrine (e.g.,
salivary alpha amylase), physiological (i.e., skin conductance), and self-report assessments (i.e., state-anxiety).
In addition, behavioral performance and reaction-time data will be used to assess the impact of stress on
cognitive control. Aim 3 will determine if neural biomarkers of stress-induced anxiety and cognitive control
observed in a laboratory setting prospectively predict depressed and anxious mood and functional outcomes in
the context of stress in daily life. Participants will be followed for 2 weeks and will be asked to complete
assessments of their work productivity, social/family functioning, and mood randomly and in response to
physiological detection of stress. Thus, this proposal will clarify the role of the LC-NE system on cognitive
dyscontrol and its influence on functional impairment.

Public health relevance
8. Project Narrative Depression accounts for the largest percentage of years lived with disability in the United States. Decreased work productivity due to depression results in an economic cost to society estimated at $84 billion a year and can result in personal financial hardship due to job loss. This proposal aims to clarify the neural mechanisms underlying cognitive dyscontrol and functional impairment in depression disorders paving the way for selectively treating cognitive impairment across depression spectrum disorders.